Improving Drug Development Through Studies of Protein Kinase Inhibitors

Drug development is time consuming and costly with little certainty of eventually leading to an approved
medicine. As new therapies are urgently needed, research is required to scrutinize the status quo to reduce the
guesswork for a more efficient process. The overall goal of our program is to evaluate aspects of drug
development and offer new methods that expose flaws and opportunities for the accelerated delivery of new
therapies. Our projects utilize protein kinases as platforms to inform best practices relevant to virtually all drug
development campaigns. Each of our program areas are made capable of filling interrelated gaps in knowledge
because of innovative applications of our novel ATP-allosteric bivalent inhibitors (AABIs) that were originally
designed to target the epidermal growth factor receptor (EGFR). The first program area is directed to selectively
target the inactive state broadly in human kinases. Our AABIs are only able to bind the inactive state enabling
the rapid discernment of promising new targets. We will tailor AABIs in cutting-edge target engagement assays
as proteolysis targeting chimera (PROTAC) degraders to enable innovative discovery approaches of kinases in
their native cellular contexts, which will serve as inspiration for other streamlined discovery approaches in drug
discovery. The second program area seeks to use EGFR as a model system for elucidating the molecular and
structural factors that influence the activity of linked compounds. Recent progress highlights our ability to develop
structural and functional understandings of linker design relevant to fragment-based drug design in addition to
fine tuning of properties of PROTAC degraders. Our third program area sets out to acquire deeper appreciation
of what causes variabilities in covalent inhibitor activity assays that potentially confuse drug optimization. We
have discovered that covalent EGFR inhibitors exhibit large potency differences based on their chemical
properties as a result of minor changes in how activity assays are performed. Our structurally diverse covalent
EGFR AABIs allow for a maximally comprehensive analysis of these effects as they can be made with a variety
of chemical structures. The work in this program will successfully fill gaps in our knowledge related to drug
development and pave the way for the accelerated production of new therapies. Our projects are interconnected
by their ability to improve drug development enabled by innovative applications of our novel AABI kinase
inhibitors. Additionally, these efforts are designed to logically evolve in future directions for upcoming MIRA
periods relevant to developing novel kinase inhibitors and applications across diverse pharmacological
approaches including covalent inhibitors, PROTAC degraders, fragment-based drug design, and others. The PI
is the main driver of this research program with multi-disciplinary expertise and a long-term vision to leverage
the molecular and structural insights discovered in these projects to shape decision making in drug discovery,
design, and development.

Public health relevance
Narrative New drugs are needed to treat diseases, however the process by which they are produced is inefficient resulting in additional cost and time. We are working to gain knowledge through novel methods that will reduce the guesswork and streamline various aspects of drug development. In the long term, our work should lead to accelerated development of urgently needed medicines.